Geographical Management of Cancer Health Disparities Program (GMaP) P30 Administrative Supplement to Strengthen Research, Training, and Outreach

The Geographic Management of Program (GMaP) initiative is a supplement to the CCSG that is focused on strengthening cancer health disparities research and enhancing workforce diversity. This is accomplished by offering robust communication and dissemination of information to regional trainees, early stage investigators (ESIs), and potential students about the regional hub and opportunities that exist for them to enter biomedical research (especially cancer health disparities). These opportunities include: research stimulus awards, workshops, pilot grants and an expert grant review/mentorship program. Second, the creation of a virtual biorepository database reflective of racial/ethnic minority cancer site data available from across the region to be shared with regional trainees and students to create and stimulate new research. Lastly, as tracking outcomes of the hub are vital, we anticipate conducting a comprehensive survey evaluating GMaP supported career and research development opportunities and assessing potential sustainability of the existing infrastructure beyond funding from this final supplement cycle.

Public health relevance
GMaP Region 5 is an expanding team of institutions, NCI Cancer Centers, faculty researchers, community health educators, students and fellows that support our overarching goals of advancing the science of cancer health disparities research as well as supporting the next generation of cancer researchers. This is accomplished by our GMaP hub through disseminating relevant news, updates and information, offering cancer research resources including career development opportunities to underrepresented researchers, early stage investigators and scholars throughout the region in moving towards our goal of the reduction of cancer health inequities.